The Role of Cyclin C in mediating neurodegenerative proteinopathies

Alzheimer’s disease (AD), Parkinson’s disease (PD), Lewy body disease, amyotrophic lateral
sclerosis (ALS), frontotemporal lobar degeneration (FTLD), and prion disease constitute a group
of neurogenerative diseases called proteinopathies. They are characterized by the accumulation
of aggregated and misfolded proteins in the central nervous system. The identities of the
aggregated disease proteins have been identified but how they work at a mechanistic level and
contribute to disease pathogenesis remains unclear. Moreover, despite having common co-
occurring pathology, little is known about the relationship between these proteinopathies,
complicating potential treatment options. Recent evidence has shown a link between the
mitochondrial-mediated clearance of aggregated proteins and the preservation of neuronal cell
integrity. Likewise, established model systems of proteinopathies have both demonstrated similar
results and carved a way to study the molecular details of these diseases. In this grant, we
propose to the budding yeast S. cerevisiae and mammalian cells including neurons to address
the role of mitochondria and cyclin C in the clearance of the aggregated disease proteins. Of
these proteins TDP-43, has emerged as a key player in AD, ALS, and FTLD. Studies in yeast
have revealed that cyclin C, a conserved member of the Cdk8 kinase module of the mediator
complex, plays a role in TDP-43 toxicity. Our studies point to cyclin C’s known interaction with
mitochondria, contributing to TDP-43 mediated-cell death. In this proposal, we will determine the
molecular details of the relationship between cyclin C and TDP-43, mitochondria, and cell viability
in yeast (Aim 1) and mammalian systems (Aim 2). Together these studies should provide insight
into the role cyclin C plays in proteinopathies.

Public health relevance
A hallmark of many neurodegenerative diseases, including Amyotrophic Lateral Sclerosis and Alzheimer’s disease, is the cytoplasmic accumulation of TDP-43, a nuclear DNA/RNA binding protein. This research proposal will use both yeast and mammalian models of TDP-43 to uncover the molecular role cyclin C plays in TDP-43 toxicities.